Metabolomic characterization of normal aging and Alzheimer's disease under anesthesia- surgery stimuli

We propose to quantify aging- and AD-associated brain and blood metabolic changes through ex vivo and in
vivo multimodality MR measurements in mouse models after an AD-promoting stimuli, anesthesia-surgery,
with-or-without preventive, protective treatments. This approach recognizes that AD onset, pathogenesis and
progression must produce alterations in the overall metabolic status, or metabolomics, of brain and other
organs in AD patients, as compared with normal homeostasis in healthy individuals, and our understanding of
the urgent need to develop non-invasive AD diagnosis tools. In the three proposed Aims, we will (1)
Characterize age-associated metabolomic changes ex vivo using tissues from different brain regions and blood
serum obtained from wild-type and AD mice after administration of anesthesia-surgery stimuli; (2) Develop
multimodality in vivo MR protocols for non-invasive evaluations of age- and AD-associated brain metabolic
changes induced by anesthesia-surgery stimuli; and (3) Investigate the effect of an AD protective intervention
on metabolomic changes after administration of anesthesia-surgery stimuli. The success of this project will
lead us to establish translational protocols that can guide and interpret multimodality in vivo MR imaging results
by obtaining accurate ex vivo MRS, EM, and immunochemistry measurements in the proposed animal models,
and translating these findings into clinical protocols for human AD non-invasive diagnosis.

Public health relevance
Relevance Recognizing the importance for understanding age-associated metabolic changes in Alzheimer’s Disease (AD), we propose to quantify aging- and AD-associated brain and blood metabolic changes through ex vivo and in vivo multimodality MR measurements in mouse models after an AD-promoting stimuli, anesthesia- surgery, with-or-without preventive, protective treatments. This approach recognizes that AD onset, pathogenesis and progression must produce alterations in the overall metabolic status, or metabolomics, of brain and other organs in AD patients, as compared with normal homeostasis in healthy individuals, and our understanding of the urgent need to develop non-invasive AD diagnosis tools. The goal of project is thus to establish translational protocols to guide and interpret multimodality in vivo MR imaging results, based on precise measurements from ex vivo MRS, EM, and immunochemistry studies of the animal models, particularly ex vivo MRS measurements, which are difficult or impossible to conduct in human brain tissues. Success in our project can supply information critical to guiding protocol design and interpretation for in vivo multimodality MR results from human patients, thereby providing a foundation for developing methods of non- invasive detecting and monitoring of age-associated AD metabolomic changes for use in the human AD clinic, an urgently needed capability that to date has remained elusive.